Elucidating physiology of dormant bacteria to combat antibiotic persistence

PROJECT SUMMARY
The vast majority of antibiotics are ineffective at killing non-growing bacteria and it is estimated that 50% of antibiotic
tolerance cases are due to phenotypic ‘persistence’ rather than genetic resistance. Common examples of recurrent infections
include urinary tract infections of pathogenic E. coli—the most common bacterial infection in women in developed
countries—latent tuberculosis, and biofilm-forming bacteria, like the P. aeruginosa infections in cystic fibrosis patients. To
develop new strategies to combat recurring infections and persistence, we need a better understanding of the physiology of
non-growing bacteria. My laboratory aims to uncover the fundamental biophysical mechanisms that sustain bacterial
survival under non-growing conditions and growth when nutrients are abundant. Our approaches will also reveal targetable
vulnerabilities of non-growing bacteria by identifying essential survival processes in both a model organism (E. coli) and
important pathogens (E. coli, P. aeruginosa, C. difficile). In the last cycle of this award, we discovered an essential process
for starvation survival of Gram-negative bacteria. We found that bacteria spend 90% of their energy budget in starvation to
maintain their cytoplasm in a contracted state (called plasmolysis), which requires active export of salt ions. By tracking
thousands of individual bacteria during starvation over several days, we were able the capture the cell death process of E.
coli in starvation with time-lapse microscopy for the first time, confirming the critical role of plasmolysis on a single-cell
level. Our work also revealed a crucial role of the cell envelope and permeability, as well as dozens of proteins that are
critical for starvation survival. In this cycle, we will address the key question how bacteria regulate the transition into and
out of plasmolysis, the state critical for their survival, and identify the molecular players that achieve this transition.
Surprisingly, very little is known about how bacteria control their cytoplasmic osmotic pressure (turgor) as a function of
growth rate. Our lab has recently proposed counterions of ribosomal RNA as the central generator and regulator of turgor
pressure. Therefore, changes in ribosomal RNA could account for growth-rate dependent changes of turgor pressure and
degradation of ribosomal RNA may enable plasmolysis in starvation. To address these questions, we will characterize
transitions into and out of starvation in wildtype and mutant strains. Using mass spectrometry, we will measure time courses
of all major cellular osmolytes including metabolites and salt ions. Using innovative microscopy techniques like Normalized
Raman Imaging and Quantitative Phase Microscopy in combination with microfluidics, we will measure cellular biomass
density, as well as macromolecular composition during transitions into and out of plasmolysis and at different timepoints
into starvation. Combining these data with our existing proteomics analysis, we will identify pathways, processes and genes
that are important for starvation survival and characterize corresponding knockout strains. These insights will then be
synthesized in a quantitative and predictive mathematical model. This project will key reveal vulnerabilities of non-growing
bacteria that could be exploited by novel antibiotics, as well as assays that could be used to identify compounds targeting
these vulnerabilities. Given that most antibiotic screens have been done on growing bacteria and that essential physiological
processes in non-growing cells are different, it is likely that many drug targets in non-growing bacteria have been missed.

Public health relevance
PROJECT NARRATIVE Ineffectiveness of antibiotics against non-growing bacteria is a major cause of recurrent infections and the development of antibiotic resistance. Our research will generate fundamental insights into how non-growing bacteria survive and thereby identify key vulnerabilities that can be targeted by novel antibiotics.